Understanding the clinical pharmacology of marijuana-tobacco co-administration

ABSTRACT
Marijuana, a federal illegal drug, is used by millions of people across all age groups, race, and sex.
Tobacco, which causes more disease and death than any other preventable cause, is used by even more
people. Importantly, most marijuana users also use tobacco. This is concerning because evidence suggests
that the health risk of combined marijuana-tobacco use (also known as co-use) is greater than that caused by
use of marijuana by itself. Understanding what leads to or causes sustained co-use of these two substances
and the health consequences of co-use is important to preserving public health.
Studies have described intake of ∆-9-tetrahydrocannabinol (THC), the primary psychoactive chemical in
marijuana, and its effects from various marijuana-only products, including smoked, vaporized, and oral forms,
but studies assessing the combined effects of marijuana and tobacco are scarce. To the best of our
knowledge, no study has examined effects of marijuana and tobacco co-administration by systematically
changing the amount of both THC and nicotine delivered to users. This has been a barrier to understanding the
relationship between marijuana-tobacco co-use and health outcomes.
The central aim of the project is to describe the pharmacokinetics and pharmacodynamics of THC-nicotine
co-administration. In this foundational study, we will use a loose-leaf vaporizer to deliver doses of both THC
and nicotine from marijuana and tobacco, respectively. We hypothesize that marijuana-tobacco co-
administration will lead to larger effects than when the substances are used by themselves, particularly at
lower doses of THC and nicotine. This includes higher THC and nicotine intake and systemic exposure, and
more than additive cardiovascular responses. We will test these hypotheses with the following aims:
(1) Describe and compare THC and nicotine pharmacokinetics and acute physiologic effects, including,
heart rate changes, catecholamine release, skin blood flow, and platelet aggregation from various
combinations of marijuana and tobacco; (2) Describe and compare sensory and subjective effects such as
high, liking, craving reduction, and psychological reward from administration of various combinations of
marijuana and tobacco; (3) Examine differences in self-administration of THC and nicotine from various
combinations of marijuana and tobacco during ad libitum access.
This proposal will advance the field, providing one of few experimental studies on marijuana-tobacco
interaction, the first that manipulates both THC and nicotine dose. It will inform our understanding of why users
co-use marijuana and tobacco and of potential health consequences related to simultaneous THC and nicotine
intake.

Public health relevance
PROJECT NARRATIVE Emerging evidence suggests that co-use of marijuana and tobacco have greater deleterious effects on health than use of marijuana by itself. The proposed project will build on the limited research done in humans that examined the pharmacological interaction between marijuana and tobacco by manipulating both THC and nicotine dose administered to participants and characterizing THC and nicotine exposure and effects. The expected findings will help us understand the risk of co-use of marijuana and tobacco, a pattern of substance use done by a large majority of marijuana users.